Intraoperative Sensor to Comprehensively Measure Ligament Engagement During Knee Arthroplasty

Project Summary/Abstract
There is a critical unmet need for a device that directly measures ligament engagement in the operating room.
Accordingly, the overall objective of this NIH Phase I STTR project is to integrate a handheld ligament
tensiometer into a custom joint distractor and test its ability to quantify metrics of ligament engagement of
interest to arthroplasty surgeons. The rationale for this project is that direct, intraoperative measurements of
ligament engagement that seamlessly fit into a standard clinical workflow will enhance surgeon’s ability to
properly balance ligaments during total knee arthroplasty. The overall objective will be achieved by completing
the following specific aims. The first aim is to integrate a handheld ligament tensiometer into an intraoperative
joint distractor to create an innovative distraction tensiometer. Both the ligament tension measurements, and
joint distraction displacements and tensions of this integrated device will be calibrated and then evaluated
against gold-standard measurements from a custom mechanical testing fixture. The milestone of success for
the first aim is that the errors in ligament tension will be less than 20% and errors in joint distraction
displacement/force will be less than 5% relative to gold-standard measurements. The second aim is to
evaluate the ability of the distraction tensiometer to quantify ligament engagement in situ. To evaluate the
ability of this device to measure ligament engagement, 2 surgical collaborators and 3 orthopedic
fellows/residents will use the distraction tensiometer to directly quantify engagement of the medial and lateral
collateral ligaments in 10 human cadaveric knees. The errors between measurements from the distraction
tensiometer and the gold-standard measurements from the University of Wisconsin–Madison’s robotic testing
system will be computed. The milestone of success for the second aim is that the errors in ligament
engagement displacement, engagement tension, and stiffness will be less than 5%, 10%, and 10%
respectively, from the gold-standard measurements. The contribution of this research will be significant
because the distraction tensiometer has the potential to redefine how surgeons set the engagements of
ligaments during total knee arthroplasty that will (1) benefit hundreds of thousands of patients per year, (2)
maximize health system reimbursements, and (3) minimize the economic burden of revision surgeries. The
proposed research is innovative because it will enable, for the first time, direct measurements of ligament
engagement during knee arthroplasty. Without such a device, surgeons will remain limited in their ability to
identify and correct ligaments with improper engagement that will in-turn limit the efficacy of total knee
arthroplasty to improve patient quality of life and alleviate the large economic burden that revision procedures
place on the healthcare system.

Public health relevance
Project Narrative The proposed research is relevant to public health because it focuses on developing a novel device to enhance intraoperative assessments of ligament engagement during procedures like total knee arthroplasty. Surgeons currently lack a sensor to directly measure ligament engagement, which limits their ability to achieve optimal post-operative outcomes for their patients. Thus, this project is relevant to the part of the NIH National Institute on Biomedical Imaging and Bioengineering’s mission to transform, through technology development, our understanding of disease and its prevention, detection, diagnosis, and treatment.